Creating and disseminating resources for the genomics and omics of behavioral and social phenotypes

Project Summary/Abstract
This proposal is an R24 research network application. The Social Science Genetic Association Consortium
(SSGAC) is a research network that provides a platform for large-scale, interdisciplinary collaborations on
genome-wide association studies (GWASs) of behavioral, social, and other aging-related phenotypes. Summary
statistics produced by the SSGAC are widely used in medical, epidemiological, and social-science research for
studying biosocial science, health disparities, and aging-related topics, and for integrated analyses with omics
including genome-wide methylation, gene expression, and brain imaging.
The overarching goal of this proposal is to create and disseminate resources for the genomics and omics of
behavioral and social phenotypes. The Specific Aims are:
• Conduct genome-wide association studies (GWAS) of a wide range of behavioral, social, and other
aging-related phenotypes in unprecedentedly large samples, using the most up-to-date methods to
maximize power, and broadly disseminate the resulting summary statistics and PGIs. In addition to
(standard) population-based GWAS (i.e., in samples of unrelated individuals) in samples with genetic
ancestries similar to those of the 1000 Genomes subsample EUR, we will also disseminate results from
family-based GWAS (i.e., controlling for parental genotypes, either measured or imputed from other
genotypes relatives) and diverse-ancestry GWAS. Diverse-ancestry GWAS may be particularly useful for
studying, and ultimately mitigating, health disparities across genetic ancestries.
• Produce and disseminate materials for non-technical audiences that address appropriate interpretation
of genomics research on behavioral and social phenotypes and its social and ethical implications.
Building on the SSGAC’s practice of accompanying every major paper with Frequently Asked Questions
(FAQs), we will convene a Community Advisory Panel to get public input on important questions that
may be missed by FAQs to date. We will write general FAQs about the field as a whole, which can then
be referenced by subsequent, briefer, paper-specific FAQs. We will create paper-specific FAQs that
address the new and major issues raised by family-based and diverse-ancestry GWAS and PGIs and
their potential uses and misuses.
• Develop new methods for analysis of summary statistics and PGIs, prepare user-friendly software
manuals, and make the software tools publicly available on a GitHub repository featuring a Q&A forum.
We will also host and advertise monthly online methods/software seminars, taught by the developers of
new methods. We will emphasize new methods that integrate the analysis of genomic summary
statistics with other omics data.

Public health relevance
Project Narrative This research network, the Social Science Genetic Association Consortium, aims to conduct large-scale genomic studies of aging, behavioral, and social phenotypes; broadly disseminate the results and any associated software to the research community, thereby producing resources that will help advance the field; produce and disseminate materials for non-technical audiences about the strengths and limitations of the field; and host monthly online seminars to teach cutting-edge methods to current and new researchers.